HIGH AND LOW POTASSIUM INTAKE IN AFRICAN AMERICANS

Designed to assess the blood pressure lowering effect of potassium supplementation in healthy African American adults who are provided with low potassium diet.